PHARMACEUTICAL RESEARCH CENTER

Long term objective: to establish a high level of competitiveness in pharmaceutical research. Specific aims: enhance faculty and student understanding- of, and capability in, proposal preparation; strengthen library holdings to support PhD tracks and research in pharmacology/ toxicology, medicinal chemistry and environmental toxicology; increase animal holding space; provide foundational support for newly hired faculty train minority recipients of PhD, PharmD, DVM, and MD degrees in pharma- ceutical research; develop new potent and safe drugs; and to investigate ethnopharmacological phenomena in certain disease states. Methods. The administrative infrastructure will identify funding opportunities, provide statistical, editorial, graphics, and word processing support, and both internal and external review for proposals. A proposal preparation and grant administration course and a state-of-the-art research seminar series will be established. Basic and supplementary text will be secured to enhance library research. CD-ROM MEDLINE, DIALOG, and National Library of Medicine on-line search capabilities will be provided. State-of-the-art cages will house mice and rats. New research oriented basic science and clinical pharmacy faculty protocols will be evaluated for the merit of requests for foundational general purpose equipment. Minority health science doctoral degree recipients will receive experience and guidance in the conduct of pharmaceutical research. New drugs will be synthesized and screened to determine activity. The bases for ethnic differences in the pharmacokinetics and pharmacodynamics of analgesics, drugs used to treat cancer, and hypertensive agents in elderly African-American and Hispanics will be studied. Restriction fragment length polymorphism techniques will be used to elucidate the molecular basis for ethnic differences in drug response.